Portable magnetofluidic platform for rapid multiplexed detection of sexually transmitted infections

Project Summary/Abstract
The 21st century has seen a rise in sexually transmitted infections (STIs) to epidemic proportions with recent
estimates of over 1 million curable STIs acquired daily. To combat the spread of STIs, diagnostics that are fast,
sensitive, and affordable are needed to accurately identify pathogens and link patients to the appropriate
treatment. Antimicrobial resistance (AMR), particularly in Neisseria gonorrhoeae (NG), threatens to aggravate
the spread of STIs with untreatable infections, so tests that also characterize the AMR profile of infections are
needed to identify the proper treatment and promote antimicrobial stewardship. Currently available diagnostics
are either too slow to guide prescribed treatment, too expensive for widespread adoption, or too limited to provide
a complete diagnosis. In this Phase I SBIR proposal, we will develop a 12-plex assay for detection of the 3
most prevalent STI pathogens- NG, Chlamydia trachomatis (CT), Trichomonas vaginalis (TV)- along with
genotypic characterization of NG AMR targets for 4 types of antimicrobials. This assay will be integrated
into low-cost magnetofluidic cartridges for fully automated sample-to-answer operation in a portable
instrument for use at the point-of-care. Magnetofluidic cartridges leverage magnetic transfer of functionalized
beads through preloaded reagents to capture, purify, and transport analytes without the need for complex fluidic
circuitry and controls that increase cost of diagnostic platforms currently on the market. Our simple extruded
thermoplastic well design enables easily scalable manufacture and focused heating using a miniaturized heat
block for rapid PCR with turnaround times under 25 minutes. High degrees of multiplexing will be achieved in
part using our recent developments in two-dimensional/two-dye (2D)-melt assays which identify amplified PCR
targets using probes encoded with both fluorophore dye color and hybridization melt temperature. Another key
innovation for multiplexing within our cartridges augments our previously demonstrated magnetofluidic
capabilities to enable distribution of captured DNA between multiple reaction wells via a sequential multi-elution
technique. The proposed work in this Phase I project will lay the foundation for a clinically relevant test with 2D-
melt assay development (Aim 1), expansion of our Prompt magnetofluidic platform to run the 2D-melt assays
(Aim 2), and validation of our assays on reference genomes and clinical isolates (Aim 3). Subsequent Phase II
funding will allow design refinement for manufacturing cartridges with automated assembly, prolonged shelf-life,
and human factors engineering.

Public health relevance
Project Narrative Currently available diagnostics are either too slow, too expensive, or too limited in scope to provide clinicians with sexually transmitted infection (STI) testing that can effectively guide treatment. This proposal aims to design a highly multiplexed assay integrated into an affordable magnetofluidic cartridge platform that can identify the most prevalent STI pathogens and provide antimicrobial resistance characterization to inform treatment options within 25 minutes. Such a test and platform would enable universal access to fast and sensitive diagnostics to halt the spread of growing STI epidemics.